Communicating Heath Advancements from Native GEnetics Research (CHANGE Research)

PROJECT SUMMARY/ABSTRACT
The American Indian and Alaska Native (AI/AN) population is increasing 3 times faster than the US population
overall. By 2050, it is predicted that 1 in 3 AI/AN Elders will be diagnosed with Alzheimer's disease and related
dementias (ADRD). Despite advances in ADRD research among non-Hispanic Whites, little is known about the
prevalence and risk factors for ADRD in AI/AN populations. This is in part due to low participation of AI/ANs in
ADRD research. The National Institute on Aging and the Alzheimer's Association have issued calls for an
increase in minority participation in ADRD research. However, success has been evasive in efforts to recruit
AI/AN populations into ADRD studies, particularly studies including biomarkers. Failure to include AI/ANs in
biomarker or ADRD research further contributes to ongoing health disparities in ADRD research and healthcare
outcomes because biomarkers are crucial in an accurate and timely diagnosis, and also play an important role
in ADRD drug development. To increase AI/AN participation in ADRD research that includes biomarkers, it is
critical to understand how to effectively communicate about biomarkers and genetic research with AI/ANs. This
information can be used to create effective communication and recruitment material for ADRD research. In this
study titled “Communicating Heath Advancements from Native GEnetics Research (CHANGE Research)” we
will apply a multi-method approach to assess AI/ANs perceptions and knowledge of ADRD research and
communication preferences. Using this information, we will create culturally tailored information material to
educate AI/ANs about ADRD and biomarkers to promote their enrollment into ADRD research. Our Specific
Aims are to: 1) partner with the United Indians of All Tribes Foundation to conduct a survey of 500 AI/AN adults
about their knowledge and perceptions of biomarker research. Survey domains will also include preferences for
health information, information seeking and opinions regarding AI/AN representation in ADRD research; 2)
interview AI/AN adults regarding cultural barriers and facilitators to participating in ADRD research involving
biomarkers. We anticipate that these interviews in conjunction with the survey results from Aim 1 will provide
insights on barriers and facilitators to participating in research involving biomarkers and effective methods to
communicate about ADRD research and biomarkers; and 3) create culturally tailored educational material and
conduct a pilot study to demonstrate feasibility of a future randomized controlled trial. This innovative application
provides an opportunity to discover critical information about how to communicate about biomarkers and ADRD
research with AI/ANs and answers the National Institute on Aging's call for research to better understand
effective strategies for recruiting minorities into ADRD research and communicating health messages that are
appropriate for diverse populations.

Public health relevance
PROJECT NARRATIVE The Communicating Heath Advancements from Native GEnetics Research (CHANGE Research) study uses an innovative, mixed methods approach to generate a communications intervention for American Indian and Alaska Native peoples. In this study, we examine the barriers and facilitators to participating in Alzheimer's disease research that includes biomarker and genetic testing, develop a communication strategy that addresses participant concerns, and finally, pilot test the feasibility of a future randomized controlled trial. Through our research on effective communication about biomarkers, we will generate strategies to inform American Indian and Alaska Native peoples about biomarkers with a goal of increasing diversity in Alzheimer's disease research.